Core C: Biostatistics and Bioinformatics

PROJECT SUMMARY/ABSTRACT: BBC
The purpose of the Biostatistics and Bioinformatics Core (BBC) is to provide professional expertise in biostatistics
and bioinformatics for all Vanderbilt-Ingram Cancer Center (VICC) SPORE in Gastrointestinal (GI) Cancer projects,
investigators, and participants. BBC support is required for all VICC GI SPORE studies; core directors and core
members are readily available to investigators and in routine contact with project and other core leaders via
standing monthly meetings or ad hoc meetings or phone calls.
One of the strengths of the VICC GI SPORE is involvement of biostatisticians and bioinformaticians from initial
project stages to project completion. Core personnel function as collaborative members of research teams to
ensure appropriate study design and methods of analysis to meet the endpoints of each project.
In the study planning phase, core personnel work with GI SPORE investigators to define study objectives and
endpoints, analyze pilot data, select an appropriate study design, devise blinding and randomization schemes, plan
interim analyses, determine early stopping rules, compute adequate sample size with concern for clinical as well
as statistical significance, estimate time required to meet recruitment goals for clinical studies, prespecify the data
analysis plan including appropriate statistical and bioinformatic methods, and prepare statistical sections of
protocols and grant applications.
During study planning, also, core personnel work with investigators and the Tissue Pathology and Cellular Analysis
Core (TPCAC) to develop a comprehensive understanding of data management needs for each VICC GI SPORE
project. According to need, core personnel then may construct one or more data capture systems; integrate existing
and/or newly developed systems; assist with refinement, expanded functionality, or standardization of existing
systems; identify opportunities for and implement automation to minimize human time and error involved in data
capture; and/or provide data quality control pipelines.
As studies are conducted, core personnel work with investigators to monitor data collection for timely data accrual;
run data quality pipelines to check and clean data; flag for review and work with investigators to address pervasive
data quality concerns or other unanticipated problems that may arise during studies; execute interim analyses;
monitor study safety; prepare, adapt, or develop methodology according to the predefined data analysis plan; and
test the planned analysis pipeline against representative data types as study data accrue.
After accrual of all study data, core personnel work with investigators to re-examine data, implement analysis
pipelines according to the prespecified data analysis plan, generate statistical tables and figures, and write
statistical and bioinformatic inputs and results for publication.